Mechanisms of contractile dysfunction in the obstructed bladder: Role of desmin and vimentin

Abstract
Lower urinary tract dysfunction (LUTD) is a common disease whose incidence and prevalence increase as the
population ages and the the current therapeutic approaches are ineffective. LUTD is strongly associated with
bladder smooth muscle (BSM) hypertrophy secondary to benign prostatic hyperplasia (BPH)-induced partial
bladder outlet obstruction (PBOO). The molecular pathogenesis of BPH and BSM dysfunction is poorly
understood; filling this gap in our knowledge will likely lead to the identification of new therapeutic targets and
more effective LUTD drugs or management strategies. We and others have demonstrated that the contractile
dysfunction, increased mitochondrial ROS and reduced ATP levels of BSM in the obstructed bladder is
associated with the overexpression of the intermediate filament (IF) proteins desmin and vimentin. Previous
studies as well as preliminary data presented herein suggest JNK2 as a major effector of the BSM contractile
dysfunction induced by the overexpression of desmin and vimentin and demonstrate that an IFs/JNK2-
dependent mechanism contributes to the contractile dysfunction in bladder outlet obstruction. In the current
proposal we have identified via microarray significant induction of the mitochondrial protein G0S2 in human
and murine BSM strips and cells overexpressing desmin and vimentin. Our additional preliminary data further
demonstrate that inhibition of G0S2 expression decreases phospho-JNK levels, increases mitochondrial ATP,
and decreases the ROS production in desmin- and vimentin- overexpressing murine and human BSM strips
and cells. Further, we demonstrate the interaction of G0S2 with voltage-dependent anion channel (VDAC).
VDAC promotes ATP/ADP exchange across the mitochondrial outer membrane in association with adenine
nucleotide translocase and mitochondrial creatine kinase. G0S2 binding to VDAC presumably disrupts the
ATP/ADP exchange thereby, reducing the mitochondrial ATP level and increasing the mitochondrial ROS
production. We hypothesize that mitochondrial G0S2 mediates desmin- and vimentin-induced BSM contractile
dysfunction via phospho-JNK2. We further hypothesize that G0S2 interaction with the VDAC promotes the
mitochondrial ROS production and the ROS-induced phospho-JNK2 contributes to the contractile dysfunction.
Three Specific Aims are designed to address these hypotheses. In Aim 1, we will establish the role of
mitochondrial G0S2 in IF protein overexpression-induced BSM contractile dysfunction. In Aim 2 we will
determine whether IF protein overexpression-induced BSM contractile dysfunction is due to G0S2 and VDAC
interaction. In Aim 3 we will employ in vivo models to establish the role of G0S2 and JNK2 in murine PBOO
induced BSM contractile dysfunction: We expect our studies to delineate a mechanism of contractile
dysfunction mediated by G0S2 and thus identify therapeutic targets for the treatment of PBOO/LUTD.

Public health relevance
Project Narrative Benign prostatic hyperplasia (BPH) causes bladder outlet obstruction (BOO) and lower urinary tract dysfunction (LUTD) in elderly men. The intermediate filament proteins overexpression induced contractile dysfunction is associated with increased level of mitochondrial reactive oxygen species in the obstructed bladder. Our proposed experiments will investigate how the reactive oxygen species and these proteins cause BOO/LUTD, and should identify novel targets enabling new strategies and drugs to treat BOO/LUTD.